Mouse Resources and Validation Core

PROJECT SUMMARY MOUSE RESOURCE VALIDATION CORE (MRVC)
The Mouse Resources and Validation Core (MRVC) at The Jackson Laboratory (JAX) provides
centralized mouse production and model development for the Center for Systems Neurogenetics of Addiction
(CSNA). Mouse resources include the Collaborative Cross (CC) and Diversity Outbred (DO) populations, in
addition to the large JAX mouse repository of over 7,000 unique mouse strains. The MRVC will provide the
expertise and resources for validation of candidate genes through the creation of genetically engineered mouse
models and cell lines. Taking advantage of existing infrastructure in the JAX Repository, the MRVC will serve as
a centralized repository for novel mouse models of addiction generated by the CSNA to support the research
and mission of the CSNA. The Specific Aims of the MRVC are: 1) To support the Behavioral Phenotyping Core
and the Research Projects by providing cohorts of Collaborative Cross strains, Diversity Outbred mice, and
genetically engineered strains from resident JAX colonies for expanded phenotyping assays. 2) To provide
capacity for in vivo validation through the production of genetically engineered strains using CRISPR/Cas9
methods for in vivo validation of putative functional variants, and for the creation of new tool strains. 3) To serve
as a centralized repository for genetically engineered models created by the Center. The repository will archive
and provide distribution support for fully characterized mouse models created by the Center, in fulfillment of NIH
sharing obligations. In addition to the close partnership with each of the Research Projects, the MRVC will
interact closely with the other two CSNA cores, including the Behavioral Phenotyping Core to conduct complex
behavioral analysis directed at predisposing and drug self-administration traits, and the Integrative Genetics and
Genomics Core to perform multivariate data analysis and integrate behavioral data with genetic information.